Post-chemotherapy Symptom Management: Testing Intervention Sequences in a SMART Design

Nearly 15.5 million Americans have survived cancer and virtually all have experienced symptoms from cancer treatment. Numerous symptom management interventions have been tested during active treatment, yet few have addressed the continuing fatigue, pain, depression, etc. that endure following the end of treatment. Existing post-treatment symptom management research has targeted survivors months after the end of active treatment, overlooking the immediate post-treatment period. During this period, some survivors have their symptoms resolve naturally (low need for intervention), while others suffer from high symptom burden (high need for intervention), with 30% experiencing depression. Our scientific premise is that depression, which is highly prevalent, is an important cognitive and emotional barrier to undertaking self-care behaviors for managing symptoms. Building on this premise, this research will determine if addressing depressive symptoms first will allow survivors to cognitively reframe beliefs regarding the efficacy of their actions towards symptom management. Sample: The sample will be 344 ethnically diverse (at least 30% Hispanic) survivors who have a new diagnosis or localized recurrence of solid tumor cancer and elevated depression and co-morbid illnesses. Design: The SMART design incorporates two interventions with proven efficacy and addresses heterogeneity of survivors' responses by following the clinical logic of starting with one intervention, assessing its success, and continuing it when effective. High need survivors will be initially randomized to receive 1) weekly symptom assessment with referral for elevated symptoms to a printed Symptom Management and Survivorship Guide (SMSG) or 2) a more intensive intervention adding SMSG to Telephone Interpersonal Counselling (TIP-C). After 4 weeks, non-responders to SMGS alone on depression will be re-randomized to continue SMSG for 8 more weeks to allow for symptom resolution, or TIP-C will be added for the remaining 8 weeks. Specific Aim 1. Test the effects of interventions on summed index of severity of 15 post-chemotherapy symptoms (primary outcome) and symptom-specific responses and times to response (secondary outcomes). Hypothesis 1. Survivors that starts with TIP-C+SMSG versus those that start with SMSG alone created by the first randomization will have better primary and secondary outcomes at weeks 1-13. Hypothesis 2. Among non- responders to the SMSG alone after 4 weeks, survivors in TIP-C+SMSG as compared to the SMSG alone group created by the second randomization will have better primary and secondary outcomes at weeks 5-13. Hypothesis 3. Self-efficacy and social support will mediate improvements in the primary outcome at week 13. Aim 2. Compare symptom outcomes of intervention sequences against the benchmark low need group. Exploratory Aim. Explore which survivor characteristics are associated with responses to the SMSG alone during weeks 1-4 and optimal symptom outcomes during weeks 1-13. This will allow us to determine tailoring variables to inform decision rules for choosing intervention sequences for individual survivors in the future.

Public health relevance
Project Narrative This research focuses on the management of persisting symptoms that cancer survivors experience following the completion of chemotherapy. Even after treatment has ended, many survivors experience persistent fatigue, pain, depression, anxiety, insomnia, and other symptoms. This project will test two interventions to alleviate these symptoms among survivors who have elevated depressive symptoms and co-morbid illnesses and have high need for symptom management in the immediate post-chemotherapy period.